Migrant and Multi-generational Immigrant Experiences: The Effects of Stressors on Epigenetic, Behavioral, and Health-related Outcomes - Diversity Supplement

PROPOSED PROJECT ABSTRACT
Immigration can be a traumatic experience, and it is well documented that exposure to trauma negatively
impacts the mental health and well-being of Latinx immigrants. Specifically, exposure to immigration-related
exposures such as violence and detention during immigration, can result in post-traumatic stress, depression,
and anxiety. Studies show that exposure to immigration-related trauma as well as high levels of acculturative
stress are associated with psychological distress and PTSD. Specifically, 1st generation Mexican immigrants
often experience psychological distress, as evident in suicide behaviors and depression and stress related to
undocumented status. Second generation Mexican immigrants also experience discrimination and financial
stressors. All these stressors make it imperative to have equitable access to mental health services for this
population. While valuable research is available at national level to indicate that both 1st and 2nd generation
Mexican immigrants experience mental health challenges and are less likely than white Americans to seek
treatment due to related stigma and lack of health insurance, one shortcoming of this literature is lack of state-
specific data. This is important because Latinx’s immigration settlement patterns across the US have varied,
with North Carolina (NC) seeing a significant increase to more than a million in the past decade, of which 54%
identify of Mexican decent. The overall objective of this supplemental application is to collect data from the
participants in the parent award to better understand the challenges and barriers that 1st and 2nd Mexican
immigrants living in NC experience when needing and seeking mental health services. This supplement will
also support the candidate’s training goals regarding conducting qualitative interviews, quantitative data
collection, and data dissemination (manuscripts and conference presentations). The candidate will achieve this
by analyzing data from questionnaires regarding mental health access, needs and challenges, and in-depth,
semi-structured interviews. This data will enable us to address the following specific aims: (1) Assess and
compare the type of mental health care services sought and utilized, as well as challenges and barriers to
obtaining those services among 1st and 2nd generation Mexican immigrants (N=200), and (2) Delineate the
barriers, challenges, and needs associated with seeking and utilizing mental health care as well as the factors
contributing to successes with help seeking among 1st and 2nd generation Mexican immigrants (N=45).The
proposed work is expected to have a positive impact because it will bridge the gap in the literature for region-
specific data on the mental health needs and barriers experienced by 1st and 2nd generation Mexican
immigrants.

Public health relevance
PROJECT NARRATIVE First generation Mexican immigrants often experience psychological distress, as evident in suicide behaviors and depression and stress related to undocumented status while second generation Mexican immigrants also experience discrimination and financial stressors. Although these stressors may increase need for mental health services, these immigrants often do not receive appropriate services. This study will address unmet needs among 1st and 2nd generation Mexican immigrants, and factors that may limit their interest in or access to mental health services.